BREAST SCREENING PROGRAM PROJECT

The purpose of the Breast Screening Program Project (BSPP) is to develop and evaluate community program approaches to promote breast cancer screening, including mammography and breast palpation. Specific projects include: Project 1: Coordinating Community Resources to Promote Participation in Breast Screening (Worden) Project 2:Enhancing BSE Maintenance Through Self-Reward Strategies (Solomon) Project 3:Cost-Effectiveness of Breast Cancer Screening Promotion Programs (Secker-Walker) Project 4:Dissemination of Community Breast Screening Promotion Programs (Flynn)